Training Program in Environmental Epidemiology

PROJECT SUMMARY/ABSTRACT
We propose to renew the NIEHS Training Program in Environmental Epidemiology. This program seeks to
prepare outstanding researchers in environmental epidemiology through rigorous training and research
methodology. Currently in its 40th year, this program is the cornerstone of support for students working in
environmental epidemiology at the Harvard T.H. Chan School of Public Health (HSPH). We have graduated
over 200 professionals who are researchers, teachers, and consultants in environmental epidemiology and
related disciplines. Many hold leadership positions in academia, government, and the private sector. The
Program consists of two tracks: environmental epidemiology and environmental molecular epidemiology and
training for both tracks is offered at the pre- and postdoctoral levels. We leverage the rich academic
environment at HSPH, the Harvard teaching hospitals and other Harvard University schools such as the
Graduate School of Arts and Sciences to provide numerous opportunities for cutting edge research in
environmental health. We have brought together outstanding multi-disciplinary faculty mentors to provide
integrated interdisciplinary experiences and have created a specialized curriculum providing a strong
background in environmental health, exposure assessment, epidemiology, and biostatistics. The track in
environmental molecular epidemiology offers additional coursework in molecular biology, genetics, epigenetics,
etc. and opportunities to conduct research in a laboratory setting. For this funding cycle we request 6 pre- and
6 postdoctoral trainees. The predoctoral students are part of the new multidisciplinary PhD program in
Population Health Sciences with a chosen field of study in environmental health or epidemiology. The PhD
program is structured to be completed in 4 years with the first 2 years involved in coursework. Research credits
are obtained through tutorials on current problems in epidemiology and from the completion of a doctoral thesis
of substance. Postdoctoral trainees are exposed to a wide variety of interdisciplinary and integrated intellectual
offerings, including didactic instruction, seminars, professional colloquia, meetings, and academic
collaboration. Significant independent research for the postdoctoral fellows varies in duration depending on the
scope of work, but usually is between 2 to 3 years. All trainees complete individual candidate training plans
and there is ongoing evaluation of the Program. This program will continue a long history of excellence in
training successful researchers in the field of environmental epidemiology at Harvard University and in
furthering the mission of NIEHS.

Public health relevance
PROJECT NARRATIVE Knowledge about environmental epidemiology - the study of the determinants and distribution of environmental causes and contributions to disease in human populations - has grown exponentially. With major advances in methodology, exposure assessment tools, toxicology, and genomics, and the increasing appreciation for multidisciplinary expertise, the need for well-trained highly skilled researchers and clinicians in this area has never been greater. We propose, through the continuation of this training grant, to continue to provide high quality training in environmental epidemiology and related disciplines to educate the next generation of outstanding scholars and public health researchers in this vital field.